Adolescent drinking and midlife outcomes: A prospective cotwin control study

ORIGINAL ABSTRACT
Adolescence is a period when many individuals begin to experiment with alcohol, with some progressing
rapidly to abusive drinking. The acute problems associated with heavy adolescent alcohol use (e.g.,
alcohol poisoning, sexual victimization, automobile accidents) have been well documented; less certain is
whether adolescent alcohol use also has long-term consequences. Three recent reviews of the relevant
literature have come to similar conclusions: adolescent drinking is associated with adult functioning, but
the existing literature does not tell us whether these associations are causal or whether the consequences
of adolescent drinking are long-lasting. We propose to address these limitations with a prospective study
of a unique cohort of twins. These twins were initially assessed at age 17, at the early stages of alcohol
use, and again at age 20, the period in adolescence when alcohol use peaks. They were subsequently
assessed at ages 24 and 29, a period characterized by life-role transition. We now propose to assess
them at mid-life (average age of 42 years), a developmental period characterized by stability and for most
a moderation of youthful patterns of heavy drinking. The in-person assessment will cover 4 major domains
of functioning: 1) mental health, including substance use and abuse, 2) physical health and behavior, 3)
neurocognitive function, and 4) psychosocial outcomes including educational and occupational
achievement and relationship quality. We estimate that 1130 twins will participate (greater than 90% of the
surviving members of the original cohort) in the in-person assessment and that 910 of their
spouses/partners will also complete a brief mail survey. Analysis of the data will document the range of
adult outcomes associated with adolescent drinking and evaluate three alternative models to account for
these effects: 1) the factors that lead to early and heavy drinking in adolescence also increase the
likelihood of deficits in adulthood (i.e., confounding), 2) adolescent heavy drinkers tend to become adult
heavy drinkers (i.e., drinking persistence), and 3) adolescent drinking upsets the normal course of adult.
The innovative cotwin control design, which controls for genetic and shared environmental factors on
outcomes, will help isolate possible causal effects of adolescent drinking on midlife functioning. The
extensive earlier assessments of this cohort will provide a wealth of information for propensity score
D
RELEVANCE (See instructions):
The project follows a large cohort of twins from age 17 to age 36-44 to identify the consequences of
heavy and abusive drinking in adolescence for functioning in mid-life. The project seeks to determine the
extent to which adolescent drinking impacts mental health, physical health, cognitive and social
functioning in mid-life and the extent to which any effects can be ameliorated by drinking desistence.